The Role of MDM2 in FMRP regulation of neuronal development

Title: The Role of MDM2 in FMRP regulation of neuronal development
Fragile X Mental Retardation Protein (FMRP) is an RNA binding protein that binds to specific mRNAs to control
their stability, localization, and protein translation. Loss of FMRP leads to Fragile X syndrome (FXS), the most
common heritable cause of intellectual disability, and is also the greatest single-gene contributor to autism.
Despite extensive effort, the mechanisms underlying the learning deficits in FXS are not fully understood and an
effective therapy for this devastating disorder is lacking. Disappointing results from recent clinical trials
underscore the pressing need for innovation in both target selection and cell type consideration. The
development of an appropriate neural network is a prerequisite for normal brain functions. Although most
neurons in the mammalian brain are born during embryonic neurogenesis, a significant amount of neuronal
development continues postnatally. Neuronal maturation, including dendritic and axonal morphogenesis, spine
development, synaptogenesis/pruning, and circuit integration, is critical for proper brain function and human
health. In addition, new glutamatergic neurons are continuously produced in the dentate gyrus (DG) of the
hippocampus, one of a few brain regions, possibly the only region in humans, with lifelong neurogenesis.
Postnatal neurogenesis is important for cognitive outcomes and its impairment is implicated in both
neuropsychiatric disorders and neurodegenerative diseases. Our lab has pioneered the investigation of FMRP
in postnatal neurogenesis and our work has provided a causal link between postnatal neurogenesis and cognitive
function in FXS, a postnatal developmental disorder. Using postnatal neurogenesis as a model system, we
recently discovered that FMRP controls the levels of active (phosphorylated- or P-) MDM2. We were able to use
a low dosage of Nutlin-3, an MDM2 inhibitor in clinical trials as a cancer treatment, to rescue cognitive deficits of
adult FXS mice. Elevated MDM2 activity is found in a number of disease conditions, mostly cancers, and has
been a focus for drug targeting. However, how elevated MDM2 impacts neurodevelopment and neuropsychiatric
disorders is unclear. Our preliminary data show that FMRP-deficiency neurons also have elevated MDM2 levels
and MDM2 inhibition rescue neuronal dendritic deficits of these neurons. Our exciting results have presented us
with a set of lingering questions that are central to our understanding of FMRP regulation of neuronal
development and developing novel treatment for FXS. This proposal aims to test the hypothesis that MDM2 is a
key mediator of FMRP regulation of neurodevelopment. We will determine whether genetic reduction of MDM2
during postnatal development rescue certain behavioral deficits of FMRP-deficient mice (Aim 1), determine
whether MDM2 dysregulation contributes to developmental deficits of FMRP-deficient neurons (Aim 2), and
identify proteins and pathways that mediate MDM2 inhibition rescue of FMRP deficiency (Aim 3). The outcome
of this study will yield important new information leading to novel therapeutic applications for FXS and potentially
other neurodevelopmental disorders as well.

Public health relevance
PROJECT NARRATIVE Characterizing the role of FMRP in regulating postnatal neuronal development and the function of MDM2 in this process will provide insights into the mechanisms underlying mammalian neuronal development, which could have significant implication in understanding and treating mental disorders including not only Fragile X syndrome but also autism, depression, and other cognitive deficits.